ADMINISTRATION OF SB202026 IN PATIENTS WITH ALZHEIMERS

This project is designed to allow patients who have participated in the dose-ranging trial to have access to open-label therapy with this medication.